PREVENTION OF RECURRENT ULCER IN PATIENTS INFECTED WITH H PYLORI

Determine whether daily gastric acid suppression with histamine-2-receptor antagonists will reduce the recurrence rate of peptic ulcer bleeding in patients who have had helicobacter pylori eradicated.